Relationship between DNA damage detection and signaling

Our most recent work used CRISPR-Cas9 nicking enzymes to examine the interaction between the replication machinery and single-strand breaks, one of the most common forms of endogenous DNA damage. In work done over the last year, we show that replication fork collapse at leading-strand nicks generates resected single-ended double-strand breaks (seDSBs) that are repaired by homologous recombination (HR). If these seDSBs are not promptly repaired, arrival of adjacent forks creates double-ended DSBs (deDSBs), which drive genomic scarring in HR-deficient cancers. deDSBs can also be generated directly when the replication fork bypasses lagging-strand nicks. Unlike deDSBs produced independently of replication, end resection at nick-induced seDSBs and deDSBs is BRCA1-independent. Nevertheless, BRCA1 antagonizes 53BP1 suppression of RAD51 filament formation. Our results highlight distinctive mechanisms that maintain replication fork stability.